Optimizing the immune response by targeting the Sts enzymes

PROJECT SUMMARY
The Sts phosphatases negatively regulate signaling pathways within cells of the mammalian immune
system. Mice lacking Sts expression (Sts-/-) are profoundly resistant to infection by clinically relevant fungal
and bacterial pathogens, including Candida albicans, Francisella tularensis, and Staphylococcus aureus.
Resistance is associated with rapid pathogen clearance and reduced inflammation. Our preliminary data
demonstrates that phagocytes lacking Sts expression have enhanced microbicidal functions.
We have shown that the Sts phosphatase domain is structurally and mechanistically distinct from other
classes of protein phosphatases. We also demonstrate that the Sts active site sits in a distinct binding
pocket, and enzyme activity can be competitively inhibited with drug-like compounds. We hypothesize that
drug-mediated inhibition of Sts-1 will recapitulate the Sts-/- phenotype and lead to beneficial clinical
outcomes. Based on this hypothesis, the objective of this proposal is to identify and characterize small
molecule inhibitors of Sts-1 that can enhance leukocyte anti-microbial responses and demonstrate efficacy
in whole animal infection models. To achieve this objective, we will conduct a high-throughput screen
(HTS) of the 530K compound Scripps Drug Discovery Library. Active compounds will be extensively
characterized and thoroughly validated, using our established assays and in vivo models.
We will accomplish our objective by completing the following Specific Aims:
Specific Aim 1: Conduct a 530K compound HTS to identify inhibitors of Sts-1 phosphatase activity.
Specific Aim 2: Validate and characterize hit compounds.
Specific Aim 3: Determine the effects of Sts inhibitory compounds on host responses to microbial
infection.
Successful completion of the proposed studies will yield a set of validated small molecule inhibitors of Sts
phosphatase activity that will serve both as chemical probes of function and as leads for the development
of novel therapeutic agents. In the long term, this work is expected to provide a foundation for the
development of new clinical protocols that will significantly reduce the morbidity and mortality attributed to
systemic pathogen infections, by enhancing host immune responses.

Public health relevance
PROJECT NARRATIVE The Sts phosphatases are negative regulators of signaling pathways within cells of the immune system. Mice lacking Sts expression are profoundly resistant to infection by different microbial pathogens. We seek to develop small molecule inhibitors of Sts that can recapitulate the Sts-/- resistance phenotype. Such molecules have the potential to enhance host immune responses and improve clinical outcomes, thereby reducing the morbidity and mortality associated with a number of deadly human pathogens.